Cancer Pharmacology

CANCER PHARMACOLOGY PROGRAM
PROJECT SUMMARY/ABSTRACT
The overarching goal of the Cancer Pharmacology (CP) Program is discovery and development of more effective
cancer treatments through pharmacology-based preclinical research and technical innovation. CP has 46
Members (versus 41 for the previous funding cycle, hereafter ‘previously’) with diverse expertise, representing
21 Departments, 7 Schools, and 2 Universities, under the strong, complementary leadership of Drs. X.F.
Steven Zheng and Stephen K. Burley. CP research is focused on understanding the biology of key molecular
targets in cancer that drive cell growth, proliferation and survival so that they can be effectively targeted for
cancer therapy, to determine the modes of action and mechanisms of resistance to anticancer agents, and to
discover and develop novel therapeutics and drug delivery technologies for more effective cancer treatment.
CP was rated Outstanding to Excellent in the previous CCSG competitive renewal. In response to opportunities
for improvement identified by the review team, we developed and implemented a CP Program Strategic Plan
aligned with the overall CINJ Strategic Plan. Substantial progress has been made during the current funding
period. Outcomes include higher impact scientific and technological advancements, more effective translational
research, tighter focus on Catchment Area (CA) Priorities, and Community Outreach and Engagement
(COE). These accomplishments were enabled by strategic recruitment, intra/inter-programmatic teamwork within
the Cancer Center and with external collaborators both nationally and internationally, peer-reviewed, cancer-
relevant funding and multi-principal investigator (MPI) grants, community engagement, commitment to
mentorship of new/early career faculty and trainees, and increased representation of Princeton faculty in the
Program. During the current grant period, CP held more peer-reviewed, cancer-relevant funding ($9.6M versus
$6.5M previously), and more NCI funding ($4.3M versus $3.2M previously) and published 656 impactful, peer-
reviewed and cancer-relevant papers with 36% (versus 13% previously) appearing in high impact (impact
factor>10) journals (e.g., Cell, Nature, Science, Molecular Cell, Cell Metabolism, Nature Cancer). In addition
to basic science and technology achievements, CP members developed mathematical models to improve
treatment outcomes of immune checkpoint and chemotherapies, and novel small molecule, biologic and nano
therapeutics, and precision base-editing technology tested in clinical trials and/or licensed to biopharmaceutical
companies, significantly strengthening the Cancer Center’s translational pipeline.
Moving forward, CP will pursue integrative, multi-disciplinary approaches to research, development and
translation, leverage COE to address community and CA Priorities, and promote translational research leading
to clinical trials and commercial development that will bolster CINJ translational pipelines and improve cancer
care and patient outcomes in the State of New Jersey and across the nation.

Public health relevance
PROJECT NARRATIVE Not required per PAR-21-321 (Cancer Center Support Grants (CCSGs) for NCI-designated Cancer Centers (P30 Clinical Trial Optional)